The Impact of Dynamic Fluctuations in Caregiver Stress on Children's Language Environments, LanguageDevelopment, and School Readiness

PROJECT SUMMARY
Children’s language development and school readiness are deeply influenced by their early social
interactions with caregivers. As a child’s main interaction partners, caregiver stress can also have profound
influences on child development. The PI’s prior work, as well as the broader literature investigating
associations between caregiver stress, caregiver–child interactions, and child development, have mainly used
static, laboratory-based measures of stress and caregiver–child interactions. This foundational work fails to
capture the inherently dynamic nature of variations in caregiver stress and caregiver–child interactions.
Understanding how stress influences the caregiver–child relationship early in childhood is particularly
important, as this is a critical window for development and preparation for entering formal schooling. The
proposed work will test an innovative developmental model whereby the PI will investigate how caregiver
stress and children’s language environments co-vary in real time, with cascading effects on children’s cognitive
development. The use of innovative, real-world measurement tools, such as ecological momentary
assessment and daylong language recordings, will allow for a nuanced investigation of the daily factors that
are key for promoting child development. Results will critically advance our understanding of how time-varying
measures of children’s and caregivers’ experiences influence children’s language development and school
readiness, while also advancing the PI’s training and progression toward an independent research career. Aim
1 will characterize the variation in caregiver stress across time and daily contexts using ecological momentary
assessment. Aim 2 will determine how time-varying fluctuations in caregiver stress relate to fluctuations in
caregiver–child language interactions measured via daylong audio recordings. Aim 3 will examine how the
variability of caregiver stress and associated language interactions relate to measures of children’s language
development and school readiness. It is hypothesized that caregivers will display variation over time in
ecological assessment of stress, and that this variation will be associated with time-locked differences in
caregiver–child language interactions. Further, it is hypothesized that higher levels of caregiver–child
interactions will positively predict child developmental outcomes and may serve as a “protective factor” against
higher levels of dynamic stressors. The training aims will advance the PI’s skills in the use of ecological
momentary assessment tools, application of intensive longitudinal design and analytic approaches, and the
skills needed to independently run a productive laboratory focused on how caregiver factors influence child
development. Ultimately, this work has the potential to pinpoint targets for intervention to support
developmental outcomes for children and their caregivers who experience increased levels of stress. Improved
understanding of the predictors and mechanisms by which children learn language may guide efforts in
working with families to mitigate the long-term impacts of language learning difficulties.

Public health relevance
PROJECT NARRATIVE The proposed study will examine how dynamic fluctuations in caregiver stress relate to real-time caregiver–child interactions, and how these time-varying experiences may ultimately influence child development and school readiness. As a child’s main teacher and interaction partner, caregivers are critical in shaping the home environment to promote child development; factors such as increased stress may hinder these interactions, whereas positive experiences such as increased caregiver–child language interactions could serve as a protective factor against higher levels of caregiver stress. Results will critically advance our understanding of how time-varying measures of children’s and caregivers’ experiences influence children’s linguistic, cognitive, and social development, leading to future innovations in intervention and support for caregivers and their children who may be experiencing increased levels of stress and/or adversity.